Innovative Vaginal Girth Adjustable Dilator with Precise Dilation Monitoring, designed to Significantly Improve Patient Pain Management in Pelvic Floor Disorder Treatment

Abstract
Chronic pelvic pain associated with vaginal and pelvic floor disorders is extremely common. Various medical
conditions, including post-menopause vaginal atrophy, vaginal stenosis, sequelae of pelvic radiation therapy for
cancer treatment, dyspareunia, vulvodynia, vaginismus, and others, are known to be contributing factors to this
pain. Over 25 million women in the USA are affected annually by one of these conditions. Despite opioids' limited
efficacy in functional restoration, there has been an overreliance on them for treating chronic pelvic pain in recent
decades. Untreated conditions may result in vaginal canal narrowing and altered elasticity, affecting fertility,
menstrual flow, and sexual function, leading to severe psychological distress. This can perpetuate a cycle of
increased opioid use, escalating the risk of addiction, overdose, and long-term morbidity. Vaginal Dilation (VD)
is a conventional treatment method used as an alternative or complement to drugs, mainly employing fixed-girth
push-type dilators. However, patient adherence to VD is a significant concern, with rates dropping to as low as
25%, primarily due to pain associated with significant size jumps in fixed-girth dilator shafts, averaging a 24%
increase in girth. Most patients describe this size jump progression as painful, even traumatic. To address these
challenges, Lumina Medical introduces an innovative and affordable solution: the Upgraded Girth Adjustable
Dilators. This technology enables patients to undergo atraumatic vaginal self-dilation at home and allows
clinicians to administer atraumatic vaginal dilation. This innovation comprises two key points: 1) Our dilators'
shaft enables Static-Passive Stretching (SPS) in the vaginal canal by expanding radially in millimeter increments.
These increments are imperceptible for the user, ensuring a gentle dilation and maximizing comfort and dilation
efficiency. 2) The dilation measurement feature provides precise, real-time monitoring of dilation progress, crucial
for assessing treatment efficacy, optimizing treatment protocols, and contributing to scientific research. SPS is
the most efficient physical therapy to enhance flexibility and is both patient-friendly and highly effective in terms
of pain management. Currently, no device on the market offers an affordable SPS vaginal dilation therapy.
Building on our globally patented Girth Adjustable Dilator technology, Lumina Medical seeks to revolutionize the
vaginal dilation field. Our goal for Phase I is to determine the technical merit, feasibility, and commercial potential
of our project. Phase I will comprise: Aim 1. Transitioning to a Medical Device via High-Res 3D Printing Prototype
Development, Aim 2. Developing Advanced Prototypes via Injection Molding and Aim 3. Validate Mechanical
Performance and Surrogate Model Efficacy. Our Upgraded Girth Adjustable Dilator holds the potential to redefine
the treatment landscape for vaginal dilation, whether arising from chronic conditions or surgical procedures. By
introducing this innovative and affordable solution to the market, we aspire to benefit a vast patient demographic
and establish a new standard in vaginal care. Phase II will include extensive product non-clinical bench testing
aligning with FDA 510(k) clearance, clinical trials, and preparations for commercialization.

Public health relevance
Project Narrative The proposed research introduces an affordable innovation: the Upgraded Girth Adjustable Dilators, designed to address chronic pelvic pain, which affects over 25 million women each year in the USA. Employing Static- Passive Stretching (SPS) therapy within the vaginal canal, these devices ensure precise, gradual, and uniform dilation coupled with real-time dilation monitoring. They aim to enhance patient adherence, improve pain management, reduce opioid dependency, optimize treatment protocols, and contribute to scientific research, thereby revolutionizing the standards in affordable vaginal healthcare.